ALPHA HERPES VIRAL MEMBRANE PENETRATION GLYCOPROTEINS

My research focuses on the entry of herpes viruses into cells. Ten viral surface molecules interact with each other and with the cell surface to punch a hole into the cell. Individual molecules cannot be distinguished by the electron microscope and the complexes are too complicated to analyze by X-ray crystallography. I will propose to NIH on June 1 1993, that I make 2-D crystals of herpes viral membrane molecules alone and in combinations, image them at several angles in vitreous ice with low electron doses, and determine their 3-D structure by digitizing correlation and averaging, and Fourier analysis.